MiDiario: Mobile Intervention for Diabetes via Reflection and Introspection in My Own Words

PROJECT SUMMARY/ABSTRACT
Latino adolescents with Type 1 Diabetes (T1D) face substantial disparities in care and outcomes, making new
tools to support this population essential. Managing T1D requires a complex set of knowledge and decision-
making skills. Adolescents have specific challenges to managing T1D, including psychosocial needs for
autonomy and fitting in with peers, along with still-developing decision-making and planning skills. Additionally,
Latino adolescents face both unique challenges and a lack of access to culturally-sensitive care and support that
recognizes the unique experiences, language, and barriers for these patients. Previous research in social
psychology has demonstrated that counterfactual (“what if”) thinking paired with appropriate educational content
can improve health outcomes. Convergently, innovative culturally sensitive approaches to diabetes care and
patient education improve T1D outcomes for Latino adolescents. Although numerous mobile applications (apps)
exist for diabetes management, none currently offer a feature set targeted to this population that combines
cutting-edge behavioral science on self-efficacy and behavior change with models of culturally appropriate care.
Our preliminary studies demonstrate the impact of counterfactual reflection tasks on healthy eating intentions in
Latinos, the effects of culture on counterfactual functionality, and the benefits of culturally-sensitive care to
outcomes in Latino adolescents with T1D, offering proof-of-concept for the core assumptions of this product. In
this Phase 1 SBIR, we will build a prototype of a new app that will help Latino adolescents manage their T1D by
offering strengths-based, culturally sensitive tools to build knowledge and facilitate self-efficacy and planning.
We will achieve this through two aims. Aim 1 will optimize the design of the app through end user research and
internal testing. Aim 2 validate the acceptability and usability of the app. To do this, we will develop new reflection
tasks to facilitate self-management and validate these tasks through mixed-methods research in patient
populations. Additionally, we will test the usability and acceptability of a working prototype in the end user
population through semi-structured interviews and quantitative measurement. By creating an innovative app to
manage T1D, the planned research will offer advancements to the treatment of T1D in Latino adolescents.
Additionally, the research will provide insights into how social cognitive science can be integrated into clinical
practice to support patient efficacy in managing T1D. Beyond improving clinical care, the research will advance
social cognitive psychology by investigating the functionality of counterfactual reflection and intention generation
in a novel health domain. Together, these innovations will address a critical disparity in health to advance healthy
living for Latino Americans as well as offering new tools for future innovations to reduce disparities in related
domains.

Public health relevance
PROJECT NARRATIVE Hispanic and Latino teens face numerous challenges to the complex task of managing Type 1 Diabetes, and as a result have inequities in health outcomes. To address this disparity, the proposed research will leverage cutting- edge behavioral science principles from social cognitive psychology and best practices for culturally-attuned care to develop an innovative mobile application (app) that offers easy-to-use, culturally sensitive tools to help teens manage their diabetes through smart coaching that provides feedback, educational content, and self-refection prompts, as well as summary reports to aid family and care team communication. The tools developed in this research will offer new approaches to improve the health of Latino adolescents with Type 1 diabetes, and may also be useful in developing tools to help other groups (such as Latino adults) and medical conditions (such as Type 2 diabetes).